Observation of Environment and Reproductive-Endocrine Effects

We launched this study over summer of 2024 and recruited our first patient under this protocol in July 2024. We have been in touch with many potential participants that we will enroll in the coming months. We are particularly interested in recruiting subjects with polycystic ovarian syndrome, hyperandrogenism, hypogonadism and adults and children with inherited reproductive endocrine dysfunction. Over the next year, we aim to recruit study subjects, collect and analyze data and obtain preliminary insights into the relationship between lifestyle, environment and reproductive endocrine disease.